Base Title: PREVENT Preclinical Drug Development Program: Preclinical Efficacy and Intermediate Endpoint BiomarkersTask Order Title: Colorectal Cancer (CRC) Prevention by TPST-1495 in PIRC rat mod

The purpose of this Task Order is to evaluate the efficacy and preliminary safety of TPST-1495 for the prevention of Colorectal Cancer (CRC) associated with Familial Adenomatous Polyposis (FAP) in PIRC rat model. The Government will provide TPST-1495 to the Contractor for use under the effort described in the Statement of Work.